A Multicomponent Intervention to Increase HIV Risk Perceptions and PrEPInitiation among Black Men Who Have Sex With Men

PROJECT SUMMARY/ABSTRACT
Tragically, HIV infections among Black men who have sex with men (BMSM) in the U.S. persist.
Despite the availability and interest in pre-exposure prophylaxis (PrEP), effective uptake among BMSM
remains low. It is imperative to mitigate barriers to PrEP initiation among this group, which could require HIV
interventions that incorporate behavioral, biomedical, and structural strategies. The proposed theory-guided,
multi-component intervention is designed to enhance HIV risk perceptions and increase PrEP initiation among
BMSM in Baltimore City, using an existing mobile smartphone application along with peer change agents to
record and review sexual risk behaviors and encourage PrEP initiation. The proposed research and training
plan in this Mentored Research Scientist Developmental Award (K01) proposal will provide the principal
investigator, Derek T. Dangerfield II, PhD, with the skills needed in intervention design to develop into a
productive, independent investigator. The research and training aims proposed address a critical gap in HIV
prevention; it is well established that extant work has failed to substantially lower infections among BMSM
throughout the U.S. To strategically advance these training aims, this K01 proposal is crafted to facilitate
professional development and research capacities as a rising independent investigator. Targeted course work,
didactic workshops, and in-depth mentorship from experts in the domains of clinical intervention design, life
course theoretical approaches to health, and statistical analysis are incorporated to facilitate hands-on
opportunities to apply newly developed skills. The combined use of technology, peers, and PrEP leverages
existing relevant prevention strategies for a multi-component intervention. This research is innovative and
timely as it responds to federal and academic calls for carefully considerate, interdisciplinary interventions to
reduce HIV incidence among priority populations. The aims of this proposal incorporate qualitative and
quantitative research methods to explore the preferences of the components of an intervention to increase
PrEP initiation among the population. This research has implications for understanding whether the methods
used in this intervention can be applied in clinical settings or can be applied in peer-based settings to
circumvent the barriers of traditional healthcare engagement. Dr. Dangerfield will be primarily mentored by
senior investigator Jason Farley, PhD, MPH, ANP-BC, FAAN at the Johns Hopkins School of Nursing, with
additional mentoring from Drs. Chris Beyrer (Johns Hopkins Bloomberg School of Public Health), Ricky
Bluthenthal (University of Southern California Keck School of Medicine), and Renata Arrington-Sanders (Johns
Hopkins School of Medicine). Through research and didactic mentoring and training, Dr. Dangerfield will build
upon his expertise in behavioral social science to develop a successful career in designing high-impact,
multicomponent clinical interventions and reduce health disparities.

Public health relevance
PROJECT NARRATIVE The proposed study offers a three-phase study to design, refine, and pilot test an intervention to increase HIV risk perceptions and effective initiation of HIV pre-exposure prophylaxis (PrEP) among Black men who have sex with men in Baltimore, Maryland. This theory-based, multi-component strategy will utilize a mobile smartphone application along with peer change agents to increase HIV risk perception and PrEP initiation using an existing app available in Maryland. The results of this strategy have critical implications for understanding effective PrEP introduction methods to reduce HIV incidence among this high-priority population.